Understanding the role of BORCS5 in neuronal lysosomal function and neurodegeneration

Project summary
A central role for lysosomal dysfunction has been highlighted for neurodegenerative disease mechanisms across
multiple genetic forms of movement disorders linked to degeneration of dopaminergic (DA) neurons, including
Parkinson disease (PD) and dystonia. We recently identified pathogenic mutations in BORCS5 causing a form
of early-onset neurodegeneration with severe parkinsonism and dystonia. BORCS5 encodes a subunit of the
BLOC1-related complex (BORC), which is currently known to be involved in anterograde movement of
lysosomes. However, whether BORCS5 mutations contribute to neurodegeneration through disruptions of
lysosomal trafficking or other mechanisms is not known. Physiologically, most functionally mature lysosomes
are concentrated in the neuronal body and whether the presence of active lysosomes is required for normal
neuronal homeostasis in distal axons is debated. Surprisingly, while BORCS5 complete knock-out (KO) caused
the expected reduction in centrifugal lysosomal movements, BORCS5-patients’ cells carrying the disease–
causing mutation R95Q showed impaired lysosomal maturation and defects in autophagic flux, but not the
anticipated abnormalities in lysosomal cellular distribution. These findings suggest that BORCS5 is involved in
additional essential aspects of lysosomal biology and I hypothesize that dysfunction of these novel functions of
BORCS5 is central for disease pathogenesis in patients with BORCS5 mutations. Thus, I propose to investigate
the molecular mechanisms underlying BORCS5-related neurodegeneration using long-term cultures of human
iPSC-derived DA neurons on micropatterned substrates to facilitate the study of lysosomal dynamics through
high spatial and temporal resolution live cell microscopy, coupled with lysosomal function assays and
assessment of human specific DA neuron pathological phenotypes, which we have recently identified as an
important contributor to progressive lysosomal dysfunction and degeneration in human DA neurons. In aim 1, I
will investigate which aspects of BORC5 biology that are implicated in lysosomal function and autophagy are
disrupted by disease-causing mutations in DA neurons. In aim 2, I will explore how these disrupted mechanisms
contribute to downstream pathogenic events implicated in DA neuron degeneration and explore the therapeutic
potential of BORCS5 genetic manipulation in neurons from patients with genetic forms of PD and dystonia
featuring lysosomal dysfunction. Characterizing additional rare genetic causes of lysosomal dysfunction is crucial
for recognizing clinically relevant modifiers of lysosomal activity. Ultimately, this project will help understand the
complex interplay between lysosomal positioning and lysosomal activity in human DA neurons and potentially
identify novel therapeutic angles for targeting lysosomal dysfunction in neurodegeneration. Furthermore, this
proposed research and career development plan will provide me with essential new training in experimental
techniques that will facilitate my transition to independent researcher, investigating the genetics and molecular
mechanisms of lysosomal dysfunction in degenerative movement disorders, including dystonia and PD.

Public health relevance
Project narrative A central role for lysosomal dysfunction has been highlighted for neurodegenerative disease mechanisms across multiple genetic forms of movement disorders, including Parkinson disease (PD) and dystonia. The proposed research will investigate the function of BORCS5, a lysosomal gene that we recently identified as a novel genetic cause of neurodegeneration with parkinsonism and dystonia. The project will reveal mechanistic insights into the role of BORCS5 in regulating the complex interplay of lysosomal intracellular dynamics, maturation and degradative properties with the goal of identifying novel therapeutic angles for targeting lysosomal dysfunction in neurodegenerative disorders.